Patient Provider Communication Larch Supplement

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-041. Screening for lung cancer has the potential for a profound public health benefit; however, adherence to
lung cancer screening remains low in the United States. Multilevel digital health interventions, which target
patients, clinicians, and healthcare systems, offer a promising solution to address the gaps in lung cancer
screening. Digital health can improve patient-centeredness in interventions by increasing patient reach,
accessibility, and understanding through education. We propose to leverage the unique infrastructure of the
Larch trial (R01CA262015) via the proposed supplemental study in response to NOT-CA-23-041. The
proposed supplemental study is within the scope of parent grant, a pragmatic randomized trial testing patient-
centered interventions to promote adherence to repeat lung cancer screening. One intervention being tested is
the Patient Voices Video, an educational video for patients, which is delivered via Kaiser Permanente
Washington patient portal after a negative lung cancer screening scan. The supplemental study goal is to
define and understand which populations would be responsive to digital health communication for lung cancer
screening using the Patient Voice Video as a ‘use case’. More importantly, our findings will also identify which
patient populations are not reached via digital health messaging, which can influence future focal areas to
increase equity in digital health messaging for cancer screening. For this supplemental study, our aims are: 1)
Evaluate patient-, provider- and system-factors associated with Kaiser Permanente Washington patient portal
access and engagement with video messaging in the portal; and 2) Understand patient engagement with
Patient Voices Video and attitudes toward multimedia screening interventions with key informant interviews.
The proposed mixed-methods supplement study will improve our understanding of patient engagement with
digital health interventions, with high potential to inform future research to improve lung cancer screening and
increase equity in cancer care delivery.

Public health relevance
PROJECT NARRATIVE Annual lung cancer screenings are important to reduce death due to lung cancer, but most people do not return every year. Digital health interventions, like videos and electronic health record messaging, show promise to increase lung cancer screening. Our study will explore which factors are important in using digital health interventions and people’s experience using these technologies.